Transgenic/Behavior Core

SUM M ARY / ABSTRACT
Transgenic mouse models have been instrumental to research on Alzheimer’s disease (AD) and other human
neurodegenerative disorders. Cognitive and behavioral assessment of AD mouse models provides the ultimate
phenotype for which pathological mechanisms and/or biomarkers can be evaluated, and helps identify
promising targets for further clinical investigation. The veracity and availability of twenty AD mouse lines and
the validity and robustness of their phenotypes are critical to the proposed behavioral, pharmacological and
immunological studies described in Projects 2 and 3 of this PO1 proposal. The overall goal of the
Transgenic/Behavior Core (Core C) is to support the independent and synergistic animal and behavioral
requirements of these Projects. Its specific aims are to 1) establish and maintain transgenic and mutant AD
mouse model lines, 2) perform comprehensive behavioral phenotyping of the AD mouse models and 3)
determine the impact of pharmacological and immunological interventions on specific
cognitive/behavioral processes. To meet these aims, Core C will leverage specialized housing and
behavioral testing facilities in the NYU Rodent Behavior Laboratory (NYU-RBL), as well as dedicated expertise
and personnel to implement a large-scale, comprehensive behavioral phenotyping battery that includes both
“traditional” tests and innovative touchscreen paradigms. These value features of the Core will provide lab-
independent standardization and time/cost-efficiency across the multiple Projects, as well as help maximize the
robustness and clinical translation of AD mouse model phenotyping results.